CIRCADIAN ALTERATIONS IN T LYMPHOCYTE BETA ADRENOCEPTOR IN ASTHMA

To determine if exacerbation of nocturnal asthma is temporally associated with alterations in T-lymphocyte Beta 2 Adrenoceptor binding; and if nocturnal worsening of asthma is related to alterations in T-lymphocyte Beta-2 Adrenoceptor Function.